CHARACTERIZATION OF ANTIOXIDANT ENZYME

A 25-kDa antioxidant enzyme that provides protection against oxidation systems capable of generating reactive oxygen and sulfur species has previously been identified. The nature of the oxidant eliminated by, and the physiological source of reducing equivalents for this enzyme, however, were not known. The 25-kDa enzyme is now shown to be a peroxidase that reduces H202 and alkyl hydroperoxides with the use of hydrogens provided by thioredoxin, thioredoxin reductase, and NADPH. This protein is the first peroxidase to be identified that uses thioredoxin as the immediate hydrogen donor and is thus named thioredoxin peroxidase (TPx). TPx exists as a dimer of identical 25-kDa subunits that contain two cysteine residues, Cys 47 and Cys 170. Cys47-SH appears to be the site of oxidation by peroxidases and the oxidized Cys 47 probably reacts with Cys 170-SH of the other subunit to form an intermolecular disulfide. Mutant TPx proteins lacking either Cys47 or Cys 179, therefore, do not exhibit peroxidase activity. The TPx disulfide is specifically reduced by thioredoxin, but can also be reduced (less effectively) by small molecular size thiol. The Saccharomyces cerevisiae thioredoxin gene was also cloned and sequenced, and the deduced amino sequence was shown to be 51% identical to that of the Escherichia coli enzyme.